Epigenetics of the Aging Astrocyte: Implications for stroke

Project Abstract:
Menopause increases the risk and severity of ischemic stroke and the subsequent risk for dementia. Clinical
and experimental studies indicate that the loss of estrogen contributes to elevated risk for both diseases.
However, the landmark Women's Health Initiative study showed that menopause hormone therapy increased
stroke-related mortality and the risk for dementia. Our studies have shown that ischemic stroke outcomes are
worse in middle-aged, reproductive senescent (acyclic) female rats, as compared to younger, normally cycling
female rats. Moreover, estrogen replacement to the acyclic group exacerbates stroke outcomes. Our recent
studies show that the events during the acute period of ischemic stroke progress to chronic impairment in
cognition and depression, key components of a dementia-like phenotype.
In the initial funding period, we identified epigenetic changes in the aging astrocyte resulting from stroke in
reproductive senescent females. In the previous (just completed) funding period, we focused on mir20a-3p, a
member of the epigenetically modified mir17-92 cluster. Mir20a-3p shows a remarkable age-specific
regulation in the acute phase of stroke, namely profound elevation in adult female astrocytes, but
downregulation in middle-aged female astrocytes. Intravenous (IV) mir20a-3p treatment to middle-aged
females after stroke reduced infarction and sensorimotor impairment in the acute phase and attenuated
cognitive impairment in the chronic phase, indicating a role for this microRNA in stroke neuroprotection.
Cognitive impairment in our model was seen in several domains including associative learning, episodic
memory and spatial learning and recall. These impairments are abrogated with mir20a-3p treatment, and thus
offer a unique opportunity to understand the pathophysiology of stroke-induced cognitive deficits. This
competitive renewal application will focus on the mechanisms of stroke-induced cognitive impairment by
testing the hypothesis that stroke causes a sustained modification of microglial phenotypes resulting in
secondary neurodegeneration in forebrain cognitive circuits, which is attenuated by astrocytic mir20a-3p. This
proposal will therefore focus on the interactions between astrocytes and microglia, and specifically the putative
mir20a-3p target gene interleukin (IL)-17A. In three aims we will test (1) whether Il-17A, an inflammatory
cytokine, promotes cognitive impairment, by manipulating both the cytokine as well as its receptor, (2) using
`omic' approaches to determine whether stroke causes a persistent phenotypic and functional change in
microglia associated with secondary neurodegeneration, and if these changes are prevented by mir20a-3p, and
finally (3) to test the impact of endocrine signaling by mir20a-3p in middle-aged astrocytes on stroke-induced
cognitive impairment. Using translationally relevant stroke models, multiple outcome measures and gene
transfer tools, this application will critically evaluate the pathophysiology underlying the progression of acute
stroke deficits to chronic stroke outcomes, which is understudied in aging females.

Public health relevance
Project Narrative After menopause, women are at a greater risk for ischemic stroke as well stroke-associated diseases such as dementia. In order to develop more effective therapies for this disease, this application will focus on age- related changes in the functional capacity of a specific brain cell called the astrocyte, and specifically, on noncoding microRNA, that can improve short-term stroke impairment and long-term changes in cognition and affect.